INTERNATIONAL WORKSHOP ON HUMAN CHROMOSOME 15

Chromosome 15 is 3.3 % of the human genome and encompasses 105.6 megabases of DNA. Chromosome 15 has been slow to accumulate markers presumably due In part by its paucity of disease loci. A new interest has developed because of recent localization of Marfan syndrome, limb-girdle muscular dystrophy, and the Prader-Willi and Angelman syndromes and has led to the isolation of new markers for chromosome 15, as evidenced -by the number of DNA segments assigned to chromosome 15: at HGM 11 there were 66 genes and disease loci and 84 DNA segments. Several laboratories are currently isolating and mapping new highly polymorphic loci from chromosome 15 and these new markers need to be integrated into a consensus map. Consequently, now we will be able to begin to construct a map for chromosome 15. The purpose of this workshop is to consolidate data from many laboratories on both the genetic and physical mapping and to merge these maps for chromosome 15. These maps will identify overlaps in areas that researchers are currently working and identify areas that need further resolution. The workshop will be two days in June, 1992 in Tucson, Arizona. This site was chosen because of the proximity to the Muscular Dystrophy Association, which is interested in Limb-Girdle muscular dystrophy located on chromosome 15. The structure of the meeting will be a series of short presentations by each of the laboratories involved followed by an Intense working session to resolve inconsistencies in the map and to produce a consensus map.